Converting Cold to Hot Tumor Microenvironment in Prostate Cancer by Targeting Chromatin Effector

PROJECT SUMMARY/ABSTRACT
Metastatic prostate cancer (PCa) remains incurable and lethal. Immunotherapy using immune checkpoint
blockade (ICB) antibodies revolutionized cancer treatment, yet advanced PCa is refractory to ICB therapy. PCa
has limited infiltration of effector cytotoxic T lymphocytes (CTLs), which may contribute to ICB resistance.
However, the mechanism shaping the cold microenvironment of PCa is poorly understood. Recently, we
identified chromatin effector PYGO2 in the 1q21.3 amplicon as an oncogenic and metastatic driver for PCa (Lu
et al, 2018). PYGO2 binds to histone H3 tail methylated at lysine 4 (H3K4me) and modulates transcription. Our
preliminary results suggest that PYGO2 is an emerging signaling hub to control immunosuppression and CTL
infiltration in a Wnt/β-catenin-independent manner, yet the precise mechanism for PYGO2 function in PCa
immune evasion is unclear. Moreover, the effect of targeting PYGO2 with selective inhibitors on PCa progression
and response to immunotherapy is unknown. Therefore, there is a significant need to unravel the function,
mechanism and targeting strategy of PYGO2 in order to enhance immunotherapy of PCa.
Our central hypothesis is that PYGO2 is a major cancer cell-intrinsic mechanism to shape the
immunosuppressive microenvironment in PCa, and ICB therapy can be significantly enhanced by PYGO2
inhibition using novel small molecule inhibitors. We propose to accomplish three Specific Aims: (Aim 1) Elucidate
the epigenetic mechanism of PYGO2 function in the immunosuppression of PCa by integrating targeted and
unbiased approaches. (Aim 2) Determine the synergistic anti-tumor effect on PCa progression and metastasis
by combining PYGO2 ablation and ICB therapy. (Aim 3) Identify small molecule inhibitors of PYGO2 with anti-
tumor activity as single agent and in combination with immunotherapy.
Upon completion of the project, we expect to illuminate novel molecular and cellular mechanisms
underlying the role of PYGO2 in immune evasion of the PCa tumor microenvironment, establish the key
preclinical evidence on co-targeting PYGO2 and immune checkpoint pathways as a new strategy of effective
combination immunotherapy, and identify selective PYGO2 inhibitors with potent anti-tumor activity when used
as single agent or in combination with immunotherapy. Our results will advance understanding of how genetic
changes in cancer cells (i.e. PYGO2 amplification) can shape the cold tumor microenvironment. Given the
aberrant upregulation of PYGO2 in many cancer types, our studies are relevant to a large population of cancer
patients. In the long term, we envision that the bench-to-bedside translation of our findings through development
and clinical testing of the PYGO2 inhibitor(s) may accelerate the therapeutic application of the combined
epigenetic modulation and immunotherapy to the curative treatment of PCa and other cancers.

Public health relevance
PROJECT NARRATIVE As the most commonly diagnosed noncutaneous malignancy and the second leading cause of cancer mortality for American men, prostate cancer remains an important public health concern. Advanced prostate cancer is resistant to therapeutics blocking immune checkpoint molecules such as PD1 or CTLA4 with the cold tumor microenvironment as a major contributing factor. Upon completion of our project, we will define the functional role and mechanisms of the chromatin regulatory protein PYGO2 (frequently amplified in advanced prostate cancer) as the key signaling hub to foster the cold prostate tumor microenvironment, and identify PYGO2 inhibitors with the potential to turn the microenvironment from cold to hot and enhance the response of prostate cancer to immunotherapy.